Laser-based high content imaging microscope

Project Summary
High-content automated fluorescence imaging is a broadly useful cell-level bioassay platform technology that
can be used to interrogate biological systems in the context of drug discovery, and genetic perturbations and to
characterize physiologically relevant complex culture systems like patient-derived organoids. High-Content
Screening (HCS) and High-Content Analysis (HCA) are methods that combine high-throughput automated
fluorescence imaging and machine vision to extract spatially resolved, quantitative single-cell data used in drug
discovery and biological research. In the past 5 years, there has been a confluence of significant
advancements in high-content imaging hardware, precision patient modeling using organoids, and deep-
learning analysis tools that have significantly increased the utility of these methods. Typically, mammalian cells
are plated in multi-well dishes and are then incubated with substances, and after an incubation period, the
cellular morphology, and biomarkers of interest can be probed using fluorescent markers to quantitate the
effect and to gain information into the mechanism of action. HCS is one of the main modalities of phenotypic
screening wherein thousands of compounds/conditions can be tested to deliver a single-cell and multivariate
readout toward the identification of compounds/conditions with therapeutic potential in cell-based disease
models. Conventional fluorescence microscopy is low throughput and generally yields qualitative results to
support other experimental methodologies. HCS addresses both the bottleneck in data acquisition through
automation and analysis with machine vision software used to identify cells and extract biomarker intensity and
morphologic features for further analysis. Additionally, the quality of the high-content microscope, optics, and
robotic control directly influence the types of experiments that can be achieved with the more advanced
microscopes being capable of higher throughput, live-cell analysis, drug dispensing, and higher resolution
confocal fluorescence images. The Yokogawa CellVoyager 8000 is a state-of-the-art high-content imaging
platform that has 4-cameras, spinning disc confocal with water-immersion objective lenses that can
accommodate fixed or live cells in a wide array of samples/formats. The U-M Center for Drug Repurposing has
extensive experience in the development of highly physiologically-relevant in vitro disease models, high-
content assay development, and in conducting large-scale high throughput screening. There is currently no
laser-based high-content imaging microscope at U-M. The addition of the Yokogawa CellVoyager 8000 will
significantly enhance drug discovery, drug repurposing, and quantitative biological imaging efforts at U-M.

Public health relevance
Project Narrative The U-M Center for Drug Repurposing seeks to enhance its high-content imaging capabilities through the acquisition of a Yokogawa CellVoyager 8000 and integrated robotics to serve the needs of a large number of NIH-funded laboratories. The resources of the U-M Center for Drug Repurposing are available to all researchers at U-M and will facilitate quantitative biological imaging and high-content screening.